Targeting large-scale networks in depression with real-time fMRI neurofeedback

Abstract
Major depressive disorder (MDD) is a common, debilitating illness, and new treatments are desperately
needed. Addressing this critical need, this exploratory R21 proposal will use real-time fMRI neurofeedback
(rtfMRI-NF), which has demonstrated that individuals can self-modulate brain activity. Training patients with
depression with rtfMRI-NF paradigms has demonstrated promising, but modest, improvement in depressive
symptoms, and new refinements in targeting key brain networks should generate better therapeutic leverage.
fMRI studies of large-scale networks (LSN) in the brain have identified aberrant connectivity within and
between networks in MDD, as well as other psychiatric disorders. Accordingly, this proposal will develop a new
rtfMRI-NF paradigm that specifically targets interactions between two large-scale networks, critical for healthy
psychological functioning – the salience network (SN) and the default-mode network (DMN). A fundamental
observation of LSNs is that the DMN, activated by internally generated content, deactivates during tasks
requiring attention to external stimuli. The SN, along with other ‘task positive’ networks, exhibit a reciprocal
relationship with the DMN, becoming active in tasks requiring external direction of attention and executive
functions when the DMN deactivates. Nodes within the SN, such as the anterior insula, have been suggested
to mediate the balance between the DMN and task positive networks. As imbalanced connectivity amongst
these networks is linked to depression, methods to boost SN function may improve therapeutic responses. For
the first step in a larger program to test this hypothesis, this proposal will develop a ’Recall Stop Task’ (RST),
using rtfMRI-NF, to target “switching off” the DMN and activating the SN. Forty patients with active MDD will be
randomized in a double-blinded, controlled study. In Aim 1, during an initial (localizer) MRI session, network
participation in this network switching task will be evaluated, testing the hypothesis that SN is engaged by the
RST. For Aim 2, participants will be randomized to receive either valid NF from the personalized network
activated by the switching task during the localizer session, or they will receive sham NF. We will test the
hypothesis that real, compared to sham NF, will increase activation in the RST, and that the NF task will
increase SN connectivity. Successful development of this switching network NF paradigm will provide a robust,
neuroscience-informed target for personalized interventions designed to engage networks at the level of the
individual subject. The next step would entail an R61/R33 project to demonstrate target engagement and test
the hypothesis that symptom amelioration for MDD will follow. Although subsequent steps will focus on MDD,
benefits are predicted to be transdiagnostic.

Public health relevance
Narrative To develop improved treatments for depression, as well as other psychiatric disorders, this proposal will build upon findings from functional magnetic resonance imaging (fMRI) studies that large scale networks in the brain are “out of balance” in depression. Using a relatively new technique with fMRI, patients with depression will perform an attention-focusing task while getting real-time feedback of brain network activity to help them bring their networks back into a more balanced, and healthy, state.